HUMAN MOUSE ANTI GD2 MONOCLONAL ANTIBODY FOR ADVANCED NEUROBLASTOMA

Earlier work suggested that the efficacy of the mouse monoclonal Mab 14G2a is limited by an antibody response in the treated patients. Thus, a chimeric human-mouse monoclonal has been produced against the GD2 antigens and will be tested in this Phase 1 study.